EFFECT OF BODY POSITION ON BREATHING AND PULMONARY MECHANICS IN INFANTS

This study will evaluate whether an infants sleeping position will influence the way the infant is breathing and the oxygen level in the body.